GENETIC ANALYSIS OF THE GONOCOCCUS

My broad objective is to understand how recombination impacts upon the biology of Neisseria gonorrhoeae with special emphasis towards elucidating the molecular mechanism underlying pilin antigenic variation. The neisseria as a genus show a remarkable propensity for undergoing homologous recombination both within a species and between closely related members of the genus. Such promiscuity allows the dissemination of chromosomal genetic elements throughout a population within nature, leading to a large repertoire of variant subtypes. Consequently, the presence of large variant populations makes therapeutic intervention more difficult and impairs the efficacy of many vaccine candidates.